CTSA Predoctoral T32 at Albert Einstein College of Medicine

ABSTRACT
This application seeks to continue a longstanding CTSA-supported predoctoral program, the PhD in Clinical
Investigation (PCI) at the Albert Einstein College of Medicine (Einstein). PCI combines specialized training to
prepare biomedical scientists to understand and appreciate the methodologies of clinical and population
science, to practice team science as both leaders and members of research teams, and to advance the
discipline of translational science. PCI leverages Einstein's longstanding success in fundamental laboratory-
based research. PCI's unique integration with our master's degree-granting Clinical Research Training
Program (CRTP), along with our requirement that each student's research and mentoring team must “bridge a
translational divide,” fosters multidisciplinary team science while teaching the methodologies to overcome
barriers plaguing translational research. PCI has (1) conferred 18 PhDs, (2) 12 current trainees, (3) sustained
enrollment of trainees from historically marginalized communities (HMCs), and (4) a dramatic increase in
inquiries and applicants. Einstein is located in the Bronx, NY, the most diverse and poorest urban county in the
United States, whose catchment area experiences racial and ethnic disparities in health outcomes related to
cancer, cardiovascular disease, and infectious diseases. Since much of our trainees' research involves patient
data and samples from our catchment area, PCI has essentially been training trainees to conduct clinical and
translational science (TS) research that meaningfully contributes to our understanding and mitigation of
disparities that disproportionately affect HMCs. Building from our program's success and increased demand,
we seek to evolve PCI during the next funding period with formalized emphasis on integrating health equity
(HE) into our training and ensuring program sustainability. We will integrate health disparities research with a
focus on overcoming barriers to HE into our training though collaboration with the Community and Stakeholder
Engagement Research Module of our companion CTSA UM1. We will improve training of the next generation
of trainees, who have been unfavorably affected by the COVID-19 pandemic, by establishing the position of
Associate Director for Student Support. We will improve sustainability by developing a PCI-specific F-award
path to submission program. While the PCI is disease-agnostic, many of our trainees have undertaken
research that is highly relevant to our catchment area, particularly in relation to infectious disease, cancer, and
brain science. During the next funding period, we seek to leverage the non-categorical PCI and develop new
Research Focus Areas in Infectious Disease, Cancer Outcomes, and Brain Sciences, to integrate highly
funded mentors and provide the opportunity to bring additional disease-specific T32 grants into PCI, providing
PCI trainees funding opportunities beyond the four disease-agnostic slots sought through this application.
While our training approach will remain non-categorical, in the next project period we will seek to emphasize
these focus areas per our institutional strengths, while applying TS and HE lenses to all trainees' projects.

Public health relevance
PROJECT NARRATIVE The PhD in Clinical Investigation (PCI) at the Albert Einstein College of Medicine combines specialized training to prepare biomedical scientists to understand and appreciate the methodologies of clinical and population science, to practice team science as both leaders and members of research teams, and to advance the discipline of translational science. Building from our program's success and increased demand, we seek to evolve PCI by incorporating formalized emphases on integrating TS and health equity (HE) into our training. During the next funding period, we seek to leverage the non-categorical PCI and develop new Research Focus Areas in Infectious Disease, Cancer Outcomes, and Brain Sciences, to provide PCI trainees with funding opportunities that go beyond the four disease-agnostic slots while emphasizing our institutional strengths and applying TS and HE lenses to all trainees' projects.